PHASE II MULTICENTER STUDY COMPARING ANTIRETROVIRAL THERAPIES

This study received approval from the Performance and Safety Monitoring Board in December to continue accruing patients. Fifty-four of a projected ninety patients have been enrolled nationally thus far.